Treating Alzheimer's Disease with PMO RNA Therapeutics

ABSTRACT
Alzheimer's Disease (AD) is a devastatingly progressive, fatal neurodegenerative disease. With
approximately 30 million patients affected worldwide, it is the most common form of dementia and is
predicted to grow exponentially. The pathology of AD is driven by Amyloid Precursor Protein (APP) and
its proteolytic processed products, primarily the Aβ42 peptide, leading to amyloid plaques, Tau-
containing neurofibrillary tangles and neuron death. Although there are now multiple FDA approved
drugs to treat AD, including monoclonal antibodies (mAbs) that target Aβ plagues, unfortunately none of
these target the root cause of AD, namely APP. Consequently, there remains a great unmet medical
need to develop AD therapies that selectively target APP driven pathogenesis to prevent cognitive
dysfunction and neuron death.
The field of RNA therapeutics has come of age in the clinics. There are currently 16 FDA approved RNA
therapeutics, including 4x Phosphorodiamidate Morpholino Oligonucleotides (PMO-ASOs), 7x
Phosphorothioate Anti-Sense Oligonucleotides (PS-ASOs) and 5x siRNAs, with >50 ongoing early and
late stage clinical trials. Due to their Watson-Cricket base pairing mechanism of target engagement,
RNA therapeutics have exquisite on-target selectivity for all mRNAs, including APP, with minimal off-
target genetic effects. Impressively, a single RNA therapeutic dose can achieve a 3 to 6 month
pharmacodynamic response in the clinics. However, endosomal escape remains the rate-limiting
problem to solve with only ~1% of PS-ASOs and 0.3% of siRNAs escaping from endosomes. Due to the
endosomal escape problem, PS-ASO and siRNA therapeutics require excessively high doses resulting in
cytotoxicity and safety profile concerns. In contrast to siRNAs and PS-ASOs, non-protein binding PMO
ASOs can be dosed 20-times higher than PS-ASOs with no safety signals arising. Moreover, have
longest metabolic stability and duration of response. To selectively target APP, we will develop new
technology to generate a highly efficacious APP PMO therapeutic that efficiently escape the endosome
by conjugation to a universal endosomal escape domain (uEED). We will test and optimize hAPP PMO-
uEEDs in a humanized APP mouse model of Alzheimer's Disease.

Public health relevance
NARRATIVE Alzheimer's Disease, the most common form of dementia, is a devastatingly progressive and fatal neurodegenerative disease with approximately 30 million patients affected worldwide. Amyloid Precursor Protein (APP) drives Alzheimer's Disease and although there are now several FDA approved drugs to treat Alzheimer's Disease, unfortunately none of these target the root cause of Alzheimer's Disease, namely APP. We will develop a second-generation, high efficiency RNA therapeutic that selectively targets APP in neurons and test this in mouse models.